High-throughput experimental determination and computational prediction of variant effects in yeast

Project Summary/Abstract
The broad objective of the proposed research is to achieve comprehensive understanding of the effects of
DNA sequence variants on complex and quantitative traits in the yeast S. cerevisiae, arguably the most
powerful eukaryotic model system due to its small genome, ease of genetic manipulation, and the ability to
generate very large sample sizes. Evolutionary conservation has also ensured that many yeast traits have
direct parallels to biomedically important human phenotypes. We seek to comprehensively identify the DNA
loci and the candidate sequence variants within them that underlie genetic variation in fitness and expression
traits, experimentally engineer and test the effects of variants on a massive scale, and build rules for predicting
the functional effects of variants of unknown significance. Success in answering these questions will provide
critical guidance for the design of genotype-phenotype studies in humans and other organisms of medical,
biological, and agricultural interest, and enable improved diagnostic accuracy based on genome sequencing of
patients. Specifically, we will leverage single-cell sequencing to massively scale up genetic mapping in order to
increase statistical power and resolution of rare and common variant discovery. We will generate a mapping
population of millions of genetically diverse yeast by using CRISPR/Cas9 and other strain engineering tools to
facilitate crossing, selection of haploids, and incorporation of DNA barcodes. The mapping population will be
genotyped and phenotyped for both genome-wide transcript abundance and multiple fitness traits, to provide a
much richer sampling of the regulatory and other functional effects of natural yeast genetic variants, particularly
rare genetic variants. We will then employ a CRISPR/Cas9-based strategy to engineer variants in parallel on a
large scale and assess their effects in yeast through phenotypic assays. This approach involves designing
libraries of edit-directing plasmids that incorporate a specific variant at the target location. The phenotypic
assays rely on DNA barcoding and ultra-high-throughput sequencing. We will use statistical approaches to
analyze the data and control for errors and false discoveries. We also plan to validate the efficiency of the
system and improve the experimental design by evaluating the effects of various parameters. Finally, we will
build improved predictive models of variant effects in yeast, using large data sets generated here in
conjunction with existing yeast functional information. The focus will be on predicting the effects of coding and
non-coding variants on fitness traits, with machine learning and artificial intelligence models that incorporate
local sequence context, eQTL effects, and variant features such as allele frequency, functional scores, and
evolutionary conservation. The performance of the predictive model will be evaluated on newly engineered
variants, and the models will be improved through iterative cycles of feature selection, training, and
experimental testing.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Differences in genome sequence underlie susceptibility to virtually every human disease, and predicting the effects of specific sequence differences is a crucial step in improving diagnosis, prevention, and treatment. Such predictions are currently challenging for differences that lead to changes in proteins, and all but impossible for differences that may instead alter the abundance of proteins. The proposed research will enable development of more accurate predictive models of the effects on health of all types of sequence sequence differences with currently unclear significance, leading to better diagnostic precision.